Piezo1 Mobility Dynamics in Mechanotransduction

Project Summary/Abstract:
The mechanically-activated ion channel Piezo1 plays diverse roles in various physiological processes,
including the differentiation of neural stem/progenitor cells. However, the subcellular diffusion dynamics of the
channel, and how these characteristics contribute to its function, are unknown.
Single-particle tracking analysis suggests that Piezo1 diffusion is affected by cellular architecture (e.g.
actin cytoskeleton and the lipid environment). We have previously reported in square-shaped cells that Piezo1
is most active in high traction force regions (edges and vertices). Given Piezo1’s diverse role in
mechanotransduction and neurodevelopment, it is necessary to understand the role of Piezo1 diffusion in
these biological processes.
I hypothesize that channel activity and cellular mechanics determine Piezo1 diffusion dynamics. I will
perform single-particle tracking measurements of endogenous Piezo1 channels in human induced pluripotent
stem cell-derived neural stem cells (hiPSC-NSCs) via Total Internal Reflection Fluorescence microscopy
(TIRFM). I will image and analyze Piezo1 diffusion in conditions where (1) Piezo1 activity is pharmacologically
and genetically manipulated and (ii) cellular mechanics is manipulated .
The proposed research will elucidate the function of Piezo1’s diffusion in mechanotransduction and
bridge the gap between Piezo1 activity and diffusion.

Public health relevance
Project Narrative: All cells, including neural stem cells, sense mechanical forces and transduce these forces into electrochemical signals using mechanically-gated ion channels. When this process goes awry, it can lead to neurodevelopmental defects. Understanding the spatiotemporal mobility dynamics of these ion channels can help us understand how these mechanically-gated ion channels function and shape downstream processes, and could one day be harnessed for therapeutic purposes against neurodevelopmental and neurodegenerative diseases.